INTRINSIC FLUORESCENCE OF TRYPTOPHAN MUTANTS OF ADENYLATE KINASE

Dissociation of porcine mitochoidrial malate dehyprogenase (mMDH) using pressure, and study of the effect of alternate ligand and the disoclation curves obtained by pressure changes.